Development and Pilot Testing of a Mental Health Clinic-Based PrEP Uptake and Adherence Intervention for Women in Treatment for Trauma-Related Conditions

Pre-exposure prophylaxis (PrEP) is a highly effective HIV prevention tool but is not widely accessed by women. Women
in the southern United States account for 55% of annual HIV diagnoses, and violence and trauma are consistently linked
with increased HIV risk in these women. The long-term goal is to establish a new treatment delivery model that
integrates biomedical HIV prevention services into mental health care settings, thus removing individual and provider-
level barriers to PrEP care for women with trauma-related conditions who are at risk for HIV through problematic
substance use or risky sexual behaviors. The overall objectives are to (i) elucidate individual and provider level barriers to
PrEP uptake and adherence and, guided by the Information-Motivation-Behavioral Skills (IMB) model, (ii) establish a
mental health clinic-based behavioral intervention for increasing PrEP uptake and adherence in this population. The
central hypothesis is that, compared to standard treatment, an intervention delivered within the mental health treatment
setting that integrates knowledge, behavioral skills, and motivation to engage in and adhere to PrEP care will result in a
greater proportion of participants who fill their first PrEP prescription. In Year 1, we will conduct Stage 1A research to
identify key issues to address in developing the integrated treatment. Interview data obtained from women undergoing
mental health treatment for trauma-related conditions and their treatment providers will be used to finalize the design of
the pilot trial (Stage 1B) comparing standard treatment to the integrated (mental health treatment and HIV prevention)
intervention. The new integrated intervention will include motivational counseling guided by the IMB Model which seeks
to influence behavior change via information sharing, increasing motivation for change, and teaching behavioral skills to
increase self-efficacy. To test the hypothesis, the following specific aims will be pursued: (1) Collect information on
knowledge and attitudes about PrEP use and obtain feedback about the potential design of the integrated behavioral
intervention from women undergoing treatment for trauma-related conditions who are at risk for HIV and their; and (2)
Develop an integrated behavioral intervention to promote PrEP uptake and adherence in women undergoing treatment for
trauma-related conditions who are at high risk for HIV; and (3) Assess feasibility, acceptability and initial efficacy of the
intervention. The research proposed in this application, in the applicant’s opinion, is innovative in that the mental health
treatment setting is ideally situated to provide additional services for HIV prevention including PrEP but, to our
knowledge, full integration of PrEP services into mental health treatment for women has not been evaluated. The
research is significant because it is expected to provide scientific justification for the continued development of
behavioral interventions tailored to the unique needs of women who have experienced trauma. Ultimately, such research
can inform the development of innovative strategies to improve uptake of effective HIV prevention strategies.

Public health relevance
The proposed research is relevant to public health because it focuses on developing new interventions to increase engagement in the pre-exposure prophylaxis (PrEP) care cascade in trauma-exposed women who are at increased risk for HIV through substance use or risky sexual behaviors. Developing strategies specific to this population has the potential to decrease HIV risk in a population that has not previously been prioritized in HIV prevention research and, therefore, continues to bear a disproportionate burden of HIV related health and social consequences. Thus, the proposed research is relevant to NIH’s mission and the call to strengthen HIV prevention efforts for women in the southern US.